Investigating the Cortical Action of Psilocybin in Chronic Pain

Project Summary/Abstract
A dire need for novel chronic pain treatments has arisen due to the opioid crisis and the closure of opioid-
prescribing pain clinics, affecting over 50 million US adults. The psychedelic serotonin 2a/c receptor (5HT2a/cR)
agonist psilocybin has shown preliminary efficacy in treating various chronic pain disorders, such as cluster
headaches, fibromyalgia, cancer pain, and back pain. However, its mechanisms are still unknown. One
hypothesis is that psilocybin induces corrective neuroplasticity downstream of 5HT2Rs. While the role of cortical
5HT2aRs in neuroplasticity is known, 5HT2aR activation by psychedelics induces hallucinations, complicating
clinical applications. In contrast, cortical 5HT2cR is non-hallucinogenic and anti-addictive, making it a potentially
valuable pharmacological target. Although these receptors are Gq-coupled and excitatory in some regions,
cortical 5HT2cRs are inhibitory due to their coupling with potassium channels. Recently, I established a role for
psilocybin-induced inhibition of retrosplenial cortex (RSC) neurons responsive to an electrical foot shock in mice
in enhanced fear extinction. The RSC is one of the few cortical regions expressing 5HT2cRs on Camk2a-
expressing pyramidal neurons, which undergo significant transcriptional, morphological, and dynamic changes
in chronic pain. Chemogenetic inhibition of these neurons in mice can reduce mechanical hyperalgesia, while
excitation enhances it after spared nerve injury (SNI)-induced chronic pain, as can a single dose of 1mg/kg of
psilocybin. Therefore, I hypothesize that psilocybin ameliorates chronic pain by altering the encoding of pain in
the RSC (Aim 1) via 5HT2cR stimulation (Aim 2a) and inhibition of excitatory 5HT2cR+ neurons (Aim 2b). In Aim
1, I will perform one-photon calcium imaging to investigate the effects of psilocybin on encoding spontaneous
pain behaviors acutely, 24 hours post-acutely, and 1 week post-acutely in SNI mice. In Aim 2a, I will perform
intracranial pharmacology studies to determine the necessity and sufficiency of intra-RSC 5HT2cR stimulation
for psilocybin-ameliorated chronic pain. Finally, in Aim 2b, I will chemogenetically manipulate 5HT2cR+ RSC
neurons to determine if inhibition of these neurons is sufficient to replicate some or all effects of psilocybin.
Successful completion of these aims will provide (1) the first description of the effect of psilocybin and chronic
pain on naturalistic single-cell dynamics and (2) elucidate the role of cortical 5HT2cRs and 5HT2cR+ cells in
chronic pain relief, laying the foundation for future efforts to improve the viability of psilocybin pain therapy. The
applicant, Sophie Rogers, will receive advanced training in neurobehavioral deep-learning pain assays,
intracranial pharmacology and chemogenetics, transgenic approaches, single-cell calcium imaging,
experimental design and statistics, and computational analysis of high-dimensional neural datasets from her Co-
Mentors Drs. Gregory Corder and Maria Geffen. This NRSA F31 training will support the applicant’s current and
future research goals and enable her to impact basic neuroscience research as an independent researcher.

Public health relevance
Project Narrative The psychedelic 5HT2a/cR agonist psilocybin has demonstrated remarkable efficacy in improving human and rodent chronic neuropathic pain. Here, we will investigate the impact of psilocybin, 5HT2cRs, and 5HT2cR+ neurons on neural encoding and relief of spontaneous chronic pain behaviors in the retrosplenial cortex (RSC), a key brain regions in the etiology and relief of chronic pain. Successful completion of this project will provide new knowledge on the pharmacological and dynamical mechanisms of psilocybin-ameliorated chronic pain.